Understanding Pathways to Care for Veterans who Screen Positive for PTSD: The PTSD Access To Healthcare (PATH) Study

Background: Nearly half of Veterans who screen positive for PTSD in VA primary care clinics do not receive
VA mental health treatment. To increase timely access to VA care, we must understand Veterans’ access
pathways (the series of options offered to, and choices made by, Veterans after a positive PTSD screen that
may lead them to VA care). Mapping these pathways is key to understanding who is being lost to VA care and
where they are being lost. Further, by examining contextual and individual factors that predict who and where
Veterans are falling off these pathways, we will be able to ascertain why these Veterans are being lost.
Significance: The proposed IIR is responsive to the HSR&D priorities of both mental health and access to
care and will provide insight into the impact of the MISSION Act on mental health access. At the completion of
this project, we will provide three distinct deliverables: 1) guidance on where and to whom access interventions
should be targeted; 2) policy and practice guidance to aid providers in linking Veterans who screen positive to
effective VA care; and 3) a method for classifying Veterans from screening to VA mental health care, which
could be extended to other conditions (e.g. suicidality).
Innovation and Impact: Past research designed to provide information to improve access to PTSD care has
been limited by focusing on the end goal (whether these Veterans do or do not access care) rather than the
process by which Veterans arrive at this goal (the access pathways). The proposed project is not only one of
the first to consider access to care as a process rather than an end point, it is the only study to propose
examining the process of access comprehensively using a method that will generalize to the VA system as a
whole, and will be applicable to other healthcare conditions identified by VA-based screening.
Specific Aims: The proposed mixed methods study has the following aims:
1. Aim 1: Identify contextual- and individual-level variables that differentiate Veterans classified into a VA initial
access step (an immediate response to a positive PTSD screen in primary care likely to lead to VA care;
e.g., referral to PC-MHI) from those who were not, including those referred to community care via the
MISSION Act.
2. Aim 2: Understand VA providers’ and patients’ experiences with, and perspectives on, why Veterans are lost
to VA follow-up care immediately after screening positive for PTSD, including the role of the MISSION Act.
3. Aim 3: Map the access pathway steps hypothesized to follow each of the six initial VA access steps, as well
as the step hypothesized to lead to community care provided via the MISSION Act, by leveraging the
methods developed in our pilot work.
Methodology: Aim 1 will include all Veterans with new PTSD screens in primary care between FY 2017-2019.
Data from the VA Corporate Data Warehouse (CDW) will be used to determine Veteran access step
classification and to identify contextual and individual variables that significantly predict classification. Aim 2 will
use the data from Aim 1 to identify high- and low-performing sites, and qualitative interviews will be conducted
with site stakeholders to understand access barriers and facilitators. Aim 3 will use quantitative data extracted
from the VA CDW to map the remaining steps in the access pathways to identify which Veterans are lost to
follow-up, and where. Predictive models using relevant access variables identified in Aims 1 and 2 will be run.
Next Steps/Implementation: Results from the proposed IIR will inform the best ways to deploy and tailor
existing access interventions (e.g. PC-MHI, direct-to-Veteran media campaigns). We will work with the Office
of Primary Care to develop policy and practice guidance, and work with both the Office of Primary Care and
NCPTSD leadership to disseminate guidelines and our methodology to VA primary care and PC-MHI
leadership at the national level. We will begin testing implementation strategies in a subsequent IIR.

Public health relevance
VA has mandated that all Veterans be screened for PTSD annually for the first five years after military separation and every five years thereafter to identify Veterans with undiagnosed posttraumatic stress disorder (PTSD) and provide them with evidence-based interventions. Despite these efforts, nearly half of Veterans who receive a new positive PTSD screen in primary care receive no follow-up VA-based mental health care. To improve access to care for these Veterans, information is needed regarding who is being lost to follow-up, where in the process they are being lost, and why these Veterans are not receiving VA care. The immediate goals of this HSR&D IIR project are to map the pathways Veterans follow after screening positive for PTSD that may eventually lead to VA mental health care, and to understand the factors that may facilitate or hinder this process. Our findings will directly inform the development of policy guidance and the implementation of targeted access interventions, thereby improving access to VA mental health care for all Veterans with PTSD.